Advancing the Science and Practice of Ecological Momentary Assessment

Pressing Issues Page 5 of 49
Abstract
The use of repeated, momentary, real-world assessment methods known as the
Experience Sampling Method and Ecological Momentary Assessment (EMA) have been broadly
embraced over the last few decades. These methods have extended our assessment reach
beyond lengthy retrospective self-reports as they can capture everyday experiences in their
immediate context, including affect, behavior, symptoms, and cognitions. In this paper we
evaluate nine conceptual, methodological, and psychometric issues about EMA with the goal of
stimulating conversation and guiding future research on these matters: the extent to which
participants are actually reporting momentary experiences; respondents’ interpretation of
momentary questions; the use of comparison standards in responding; efforts to increase the
EMA reporting period beyond the moment to longer periods within a day; training of EMA
study participants; concerns about selection bias of respondents and selection bias of
moments; the reliability of momentary data; and, for which purposes EMA might be considered
a “gold standard” for assessment. Resolution of these issues should have far-reaching
implications for advancing the field.
119
Pressing Issues Page 6 of 49
Introduction
Behavioral science research has resulted in scores of psychometrically sound self-report
instruments about thoughts, opinions, feelings, events, and behaviors that are intended to be
summaries of significant time periods (retrospective reports) or to characterize a person’s usual
levels and dispositions across situations or over time (trait or global reports). In light of some
limitations of these traditional assessment options, researchers have long voiced desire for
methods to collect higher resolution data with greater ecological validity (Brunswik, 1941).
Higher resolution is desired so that associations between immediate contexts and experiences
can be examined and so that dynamic processes occurring over relatively short time periods
(minutes, hours, days) can be explored; greater ecological validity is desired so that observed
associations and processes are representative of respondents’ everyday lives.
These aspirations have yielded a collection of within-day momentary data capture
methodologies. Selected examples of, and reviews about, momentary research are presented
in the following papers: (Bolger, Davis, & Rafaeli, 2003; Conner & Barrett, 2012;
Csikszentmihalyi & Hunter, 2003; Degroote, DeSmet, De Bourdeaudhuij, Van Dyck, & Crombez,
2020; DeVries, 1987; Ebner-Priemer & Trull, 2009; C. D. Fisher & To, 2012; Gorin & Stone, 2001;
Hamaker & Wichers, 2017; Heron, Everhart, McHale, & Smyth, 2017; Kirtley, Lafit, Achterhof,
Hiekkaranta, & Myin-Germeys, in press; Myin-Germeys et al., 2009; Reis & Gable, 2000; Scollon,
Kim-Prieto, & Diener, 2009; S. Shiffman, A. A. Stone, & M. R. Hufford, 2008b; J. Smyth, Juth, Ma,
& Sliwinski, 2017; J.M. Smyth & Stone, 2003; Stone & Broderick, 2007; Stone, Obbarius,
Junghaenel, Wen, & Schneider, 2021; Stone & Shiffman, 1994; Stone, Shiffman, Atienza, &
Nebling, 2007; Trull & Ebner-Priemer, 2020). Several sources provide summaries and discussion
of the analytic techniques used for these complex data (Bolger & Laurenceau, 2013; Mehl &
Conner, 2011; Schwartz & Stone, 2007; Shiffman, 2014). A core feature of Ecological
Momentary Assessment (EMA) methods is the brief periods about which respondents report;
this is meant to reduce bias and error attributable to inherent memory limitations and to limit
the use of cognitive heuristics in self-reports. Relatively unobtrusive in-the-field data collection
as respondents go through their everyday lives is intended to ensure ecological validity.
Following a first generation of paper-and-pencil methodologies (DeVries, 1987), advances in
smart phone, Internet, and computer-assisted applications have further increased the appeal of
120

Public health relevance
No PHR